Aligning Patient Acuity with Resource Intensity after Major Surgery

Project Summary
The broad, long-term objective of this application is to generate an efficient, effective decision-support system to
augment postoperative triage, transfer, and discharge decisions that affect more than 15 million patients in the
United States annually. Evidence from single-institution studies suggests that postoperative overtriage of low
acuity patients to intensive care units (ICUs) is associated with low value of care (outcomes/costs) compared
with general ward admission, and that undertriage of high acuity patients to general wards is associated with
increased mortality. These associations require validation externally and prospectively. In addition, further
investigation is needed to determine whether there are similar, identifiable misalignments between patient acuity
and resource intensity occurring throughout postoperative hospital admission and at the time of hospital
discharge. Our central hypothesis is that aligning automated, data-driven patient acuity assessments with
postoperative resource intensity using explainable, fair, uncertainty-aware deep learning models will be
associated with decreased mortality and increased value of care. We will test our central hypothesis by
performing three sets of related but independent experiments. First, we will externally validate an interoperable
version of our postoperative triage classification system, initially using retrospective data at 42 hospitals across
four institutions, then performing similar analyses with retrospective data on a federated learning platform, and
finally using prospective data from 15 hospitals at two institutions. Second, we will generate continuous
postoperative patient acuity assessments with novel DL architectures using multicenter, multimodal (including
clinical notes), retrospective EHR data at three hospitals within a single institution. Third, we will critically evaluate
and optimize model certainty and fairness using retrospective data at 43 hospitals across four institutions,
generate an EHR-embedded decision-support system, and perform prospective decision support usability
testing and optimization at two institutions. The proposed research is intended to produce a validated,
interoperable postoperative triage classification system, foundational evidence for generating continuous
streams of postoperative transfer and discharge recommendations, a postoperative triage decision support
system ready for clinical implementation, and open-source software for optimizing deep learning certainty and
fairness. Achieving these outcomes would increase the probability of success for automated, real-time
postoperative triage decision-support in subsequent clinical trials, and the ultimate goal of augmenting
personalized, patient-centered decision making in surgery.

Public health relevance
Project Narrative For more than 15 million major surgeries performed in the United States annually, surgeons must decide whether the patient should receive close monitoring by specialists in a high-cost intensive care unit (ICU) or intermittent monitoring on a general ward, and when the patient can be safely discharged home. Prior work suggests that artificial intelligence models can identify cases in which doctors have opportunities to make better decisions. The purpose of this project is to design a real-world framework to help doctors make the right decision at the right time so that patients receive the resources they need while recovering safely from major surgery.